TrAstuzumab Cardiomyopathy Therapeutic Intervention with Carvedilol (TACTIC) Trial

PROJECT SUMMARY
Trastuzumab, a monoclonal directed against the human epidermal growth factor (EGF) receptor-2 (HER-2),
revolutionized HER-2-positive breast cancer treatment, albeit, with the therapy-limiting side effect of cardiotoxicity.
We found that 40% of patients experience a left ventricular ejection fraction (LVEF) decline >10% during
trastuzumab therapy, and 4% develop heart failure (HF). In 25-50% of these cases, the LVEF decline is not fully
reversible, even with cardiovascular therapy. Genetic contributors to cardiac vulnerability and the best
cardiovascular management strategy are unknown. A critical need exists for cardio-preventive approaches in
patients at risk of trastuzumab-induced cardiotoxicity.
The current application’s objective is to evaluate cardio-protective approaches using carvedilol in curative-intent
trastuzumab for HER-2-positive breast cancer. Our central hypotheses are that a pre-emptive preventive
approach (cardiovascular therapy with the beta-blocker carvedilol started before trastuzumab therapy), or a reactive
preventive approach (cardiovascular therapy started in response to early subclinical signs of cardiac dysfunction/
injury, i.e. cardiac troponin elevation or abnormal global longitudinal strain (GLS)) will reduce cardiotoxicity
compared with a standard “wait-and-see” approach (carvedilol prescribed once cardiotoxicity has occured).
We furthermore hypothesize that carvedilol extension beyond the active trastuzumab treatment leads to superior
outcomes and that pharmacogenomics can predict cardiotoxicity non-responsive to cardiovascular therapy with
carvedilol. This clinical trial will test these hypotheses, involving 450 adult breast cancer patients beginning a year of
curative-intent trastuzumab therapy, randomized to either a preemptive, a reactive, or reference care approach.
This study addresses three specific study aims:
Aim 1: To compare the incidence of a) HF or asymptomatic decline in LVEF by >10% in those with LVEF ≥50% or
≥5% in those with LVEF decrease to a nadir of <50% (lead primary aim #1), and b) reversible LVEF decline to
within 5% of baseline (secondary primary aim #1) with a pre-emptive, reactive, and “wait-and-see” approach of
carvedilol initiation in breast cancer patients over the course of adjuvant trastuzumab therapy. This aim addresses
the question of initiation of cardioprotective efforts for trastuzumab therapy.
Aim 2: To compare the delta change in LVEF from completion to 1 year post-completion of trastuzumab therapy
between a cardioprotective approach with carvedilol confined the duration of trastuzumab therapy or extended for 1
year thereafter. This aim addresses the question of duration of cardioprotective efforts for trastuzumab therapy.
Aim 3: To test the association of predefined genetic variants with change in GLS and LVEF during and after
trastuzumab therapy, adjusted for treatment arm. This aim is to identify genetic variants that predict trastuzumab
cardiotoxicity in general as well as lack of response (primary prevention of drop in LVEF or secondary improvement
of LVEF) to carvedilol.
This trial’s completion will guide clinical care in seeking the best management strategy (“tactic”) for cardio-protection
in breast cancer patients undergoing trastuzumab therapy in terms of efficacy, time of initiation, and duration of
treatment with the beta-blocker carvedilol.

Public health relevance
PROJECT NARRATIVE Breast cancer patients undergoing trastuzumab treatment are at risk of heart function decline or heart failure symptoms, but it is unknown if, when, and for how long cardiovascular protective strategies, e.g. with a beta- blocker, could help. This study randomly assigns those taking curative-intent trastuzumab to the beta-blocker carvedilol—either when significant heart function decline or subtle early signs of heart injury (either by elevation of a cardiac blood biomarker, i.e. cardiac troponin, or by an abnormal heart ultrasound marker, i.e. global longitudinal strain) are noted, or preventatively before beginning trastuzumab therapy. This study will further randomly assign those patients on carvedilol to either discontinuation at the end of trastuzumab therapy or continuation for another year, providing much needed clinical trial data on what the best strategy (“tactic”) for those at risk of cardiotoxicity with trastuzumab therapy is.